Studying the pathogenic roles of human CD8+ T cells in Alzheimer's disease using a 3D human Peripheral immune Chip.

PROJECT SUMMARY
Alzheimer’s disease (AD) is the leading cause of age-related dementia, in which neuroinflammation is
highlighted to play a critical role in driving neurodegeneration. Emerging evidence has demonstrated crucial roles
for peripheral immune cells in AD pathology by direct infiltration into brains and regulating brain-resident immune
cells, including microglia. However, many critical questions remain unaddressed. Previously, our team developed
a three-dimensional (3D) triculture model of AD with human microglia to study the interactions between microglia
and AD neural cells. Although our 3D triculture model with microglial cells recapitulates robust neuroinflammation
and neurodegeneration, it lacks another critical player in AD pathogenesis, peripheral immune cells. Therefore,
we recently developed a unique 3D multicellular human Peripheral immune Chip (PiChip) model to overcome
this limitation. This 3D neuroimmune axis model faithfully recapitulates AD pathology with innate and adaptive
immune components. Our preliminary data from the PiChip model demonstrated a dramatic increase in the
number of human T cells (but not B cells) selectively infiltrating into AD cultures versus control. Infiltration of
CD8+ T cells into AD cultures led to microglial activation and it plays a critical role in exacerbating
neuroinflammation and neurodegeneration in 3D AD PiChip models. In addition, we discovered key roles for the
C-X-C motif chemokine ligand 10 (CXCL10) and its receptor, CXCR3, in regulating T-cell infiltration into AD
cultures. Modulating this T cell CXCL10/CXCR3 signaling pathway largely prevented neuronal damage in AD
neural-glial cultures. Based on these preliminary results, we proposed a comprehensive study underlying
mechanisms of AD-specific T-cell recruitment, CD8+ T-cell mediated neural cell death, and their therapeutic
implications, using 3D human cellular models, as well as relevant AD mouse models AD models. The overarching
goal of this proposal is to use our unique multicellular PiChip system to gain a greater understanding of the
crosstalk between CD8+ T cells and brain resident cells (mainly glial cells) in driving AD pathogenesis. We will
achieve this goal by addressing the following aims: Aim 1. to study roles and therapeutic applications for blocking
T-cell mediated neuronal deficits in AD; Aim 2. to study how CD8+ T cells trigger neurodegeneration via
activating glial cells; Aim 3. to explore the roles of T cell activation and clonal expansion in AD pathogenesis.
Successful completion of these aims will provide a better understanding of AD-specific mechanisms underlying
the interaction of adaptive immune cells and brain resident cells in driving neurodegeneration, addressing a
knowledge gap that promises to yield novel insights into better interventions and biomarkers.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common form of dementia in older adults, but the contribution of the peripheral immune cells in AD pathology is yet to be fully elucidated. This is partly due to the lack of an effective and reliable model to capture the complex interactions between the various human cellular components of the brain and the peripheral immune cells. Drawing upon our considerable experience in AD biology, 3D modeling of AD in a dish, microfluidic systems, cellular engineering, and bioinformatics, we propose to study the pathogenic roles of CD8+ T cells in AD using our human cellular models and AD-like transgenic mouse models to gain a deeper understanding of CD8+ T cells biology and their disease-modifying role in AD.